Split-luciferase Epigenetic Assays for Drug Discovery

Project Summary
Epigenetic control is essential for maintaining transcriptional integrity. Regulation of the dynamic
epigenome is mediated through a range of post translational modifications on DNA and histone
tails. Histone modifications are mediated by enzymes which can be broadly classified into “writers”
that catalyze the addition of chemical modifications, “erasers” that remove the modifications, and
“readers” that can recognize chemical modifications through specific protein domains. The writing
and erasing of histone marks by enzymes is a dynamic process, and when dysregulated is
associated with cancer, inflammatory and neurological diseases.
In this application we focus on the two classes of histone modifying enzymes, lysine methyl
transferases (KMTs) and lysine demethylases (KDMs), and aim to develop and validate cell-
based assays targeting both KMTs and KDMs. These assays, based on a three-hybrid split
luciferase system, are reversible allowing dose dependent quantification of inhibitor binding.
These efforts are both significant and innovative as they can report on the direct binding of a drug
to the target protein at its intended site of action, thereby facilitating the generation of lead
therapeutic candidates and identification of chemical probes for studying histone biology and
pathways.

Public health relevance
Project Narrative Epigenetic gene regulation is important for many fundamental processes in a cell, and dysregulation is commonly associated with brain diseases and cancer. Development of assays against new epigenetic targets will help advance the discovery of new and effective therapies. The purpose of this application is to develop low-cost assays, using our platform technology, for two such epigenetic targets, the histone methylating and demethylating enzymes.